Regulation of Synaptic Rhythmicity by Astrocytic Clock

Cognitive deficits, such as learning and memory impairments, are common in people subjected to chronic
disturbance of the circadian cycle due to shift work, travel, or genetic dysregulation of the circadian clock.
Epidemiological studies have revealed a global rise in cognitive disorders with circadian disruptions comorbidity
such as autism, and Alzheimer’s disease, stressing the need to identify the causal relationship between these
phenomena. However, the molecular mechanisms linking the circadian cycle and cognitive performance in health
and disease remain largely unresolved. Neuronal synapses are the cellular basis for learning and memory
processes. Synapse number, activity, and expression levels of synaptic proteins show rhythmic time-of-day-
dependent changes, yet how these changes are regulated by the circadian clock is poorly understood. A growing
body of work supports a critical role for the glial cells, astrocytes in normal clock function. Astrocytes are
important synaptic regulators, and key for establishment and maintenance of memory and learning. In the
mammalian cortex, the development of astrocytes and synapses coincide, where synapses begin to form only
after astrocytes have been generated. Importantly, the rhythmic expression of molecular clock genes in the
cortex follows similar developmental trajectory. This suggests the hypothesis, that correct establishment of
synaptic connections and rhythmicity is linked to correct development of the circadian clock. Yet, how the
astrocytic clock regulates synaptic rhythmicity and related cognitive performance has not been thoroughly
examined. This critical gap in knowledge must be addressed in order to understand not only the fundamental
functions of the astrocytic clock, but also to characterize the regulatory mechanisms that control circadian
changes in synaptic levels. This supplemental application will define the role of astrocytic clocks in regulating
the development of synapses, synaptic rhythmicity and subsequent learning and memory behaviors in two aims.
Aim 1 investigates how early life perturbation of the astrocytic molecular clock located either in the SCN or
peripheral brain regions (e.g., cortex, hippocampus) impacts astrocyte ability to support synapse formation. In
Aim 2, we will determine how the developmental perturbations to the astrocytic clock impact time-of-day-
dependent changes in synapses and cognitive performance in adulthood. Successful completion of these aims
will uncover the role of astrocytic clock in regulating the establishment of synaptic and cognitive rhythms and
reveal strategies for future manipulation of synaptic rhythmicity through astrocyte-targeting, to restore cognitive
function in people suffering from neurological disorders.

Public health relevance
Successful completion of the proposed experiments will characterize the role of astrocytic molecular clock in regulating synaptic development and establishment of synaptic rhythmicity and cognitive performance. There is a strong comorbidity between disruptions to the circadian cycle, and cognitive impairments, yet the mechanistic link is not well understood. We will examine how developmental perturbation to astrocytic molecular clock regulates time-of-day-dependent changes in synapse number and activity, and underlying behavior.